Next Generation Tissue Analysis and Imaging Core

Project Summary/Abstract: Next Generation Tissue Analysis & Imaging Core
Research on human skin diseases has been hampered by limitations on the number of studies that can be
carried out on small skin biopsy specimens and formalin-fixed, paraffin-embedded (FFPE) specimens. This
core seeks to accelerate human skin disease research by providing access to three transformative techniques:
six color immunostaining, with spectral imaging and automated cell analyses, NanoString-based RNA and
DNA profiling and Digital Spatial Profiling. Taken together, these approaches allow comprehensive profiling of
protein, RNA and DNA targets on small samples of skin and they work equally well on FFPE samples.
Tyramide amplification based serial immunostaining allows six color labeling of FFPE specimens with no
antibody species interference; multi spectral imaging on the Mantra imaging system provides image
deconvolution and automated cell analyses, allowing identification and selective study of particular cell types
within the section. NanoString profiling allows rapid, highly quantitative measurement of up to 800 DNA or
RNA targets using minimal starting material and is the first gene expression technology to work equally well on
FFPE samples. Digital Spatial Profiling utilizes RNA and protein probes with UV sensitive linkers to provide
spatially resolved expression profiling of 10-1000s of protein or RNA targets in a section. The Core is led by
renowned dermatopathologist Dr. Martin Mihm, who will provide consultative assistance to Center users to
enhance their understanding of human skin disease. The research community can include any individual
wishing to carry out translational human skin disease research. We have included projects from 28
investigators who wish to utilize the services of this Core. In summary, this Core provides access to cutting-
edge tissue based analytic techniques that have the potential to significantly advance our understanding of
human skin diseases.